Biomolecule releasing adhesive for cell-mediated labral repair

Summary
The glenoid labrum is a fibrocartilaginous structure that lines the edge of the glenoid rim of the shoulder joint.
Glenoid labral tears, or lesions, can occur in several distinct locations (anterior, superior, or posterior) with
variable morphology (detachment from bone or intrasubstance) and have been associated with chronic shoulder
pain and/or instability. While operative intervention is typically needed to re-attach the damaged labrum to the
glenoid bone or to directly repair an intrasubstance tear of the labrum, recurrent shoulder instability and pain
following surgical repair of the labrum has been reported to be as high as 30%. This continued disability following
treatment is consistent with the poor healing capacity of the labrum. Current labral repair typically involves the
use of anchors and sutures to restore stability of the labrum and shoulder, but rarely promotes actual
regeneration of the injured labrum. Although cell therapy and tissue engineering approaches have been used to
improve cartilage and bone healing, these approaches have not been explored to improve glenoid labrum healing.
To address this deficiency in the treatment of glenoid labral injuries, it is essential to improve our knowledge of
the process of labral tear associated tissue injury and to develop a new treatment method assisting in labral
tissue regeneration and functional recovery. In our laboratory, substantial progress has been made on this front.
Briefly, click-chemistry based adhesives have been synthesized and these adhesives possess good tissue
attachment, cell/tissue compatibility, and in situ growth factor releasing property. Equally important, our studies
have uncovered an abundant source of progenitor cells in human and rat labrum tissue, which can be recruited
to the injured sites and stimulated to produce abundant extracellular matrix protein for accelerated labrum healing.
When evaluated in an in vivo glenoid labrum tear rat model, the application of bioadhesive alone suffices to
reduce 90% inflammatory cell infiltration and ~70% labral tissue erosion. By eliciting progenitor cell responses
(recruitment, proliferation, and ECM production), the application of growth factor-releasing adhesive scaffold was
found to enhance labral healing (with complete labral tear regeneration by 6 weeks vs. 50% labral
degeneration/lost in no treatment control). These exciting findings support two hypotheses. First, an adhesive
can be fabricated to serve as a scaffold matrix to bridge and seal the gap within the torn labrum, and preferentially
recruit and stimulate endogenous labral progenitor cells to the injury site for repairing and regenerating damaged
labral tissue. Second, labral tear injury mediated synovial inflammatory responses and infiltration of inflammatory
cells in and around the tear site cause labral tissue erosion. These hypotheses will be investigated through 3-
series of studies. The successful completion of the proposed work will significantly improve our understanding
of labral tear-associated tissue damage and lead to the creation of a new treatment approach for promoting
labrum regeneration complementing current surgical labral repair of torn labrum with suture anchor strategies.

Public health relevance
Project Narrative The proposed work is aimed at deciphering the processes governing labral tear-mediated tissue damage while developing a new and complementary technology for treating glenoid labral tears with improved healing outcome. The results will lead to creation of a novel, injectable, in situ-forming, and biomolecule-releasing adhesive scaffold which can reduce inflammatory response-associated tissue damage and enhancing labral tissue regeneration by eliciting the regenerative activities of endogenous labral and progenitor cells at the site of the labral tear.